Cognitive Heterogeneity in those with high Alzheimer's Disease Risk

Project Summary Please see Research Strategy

Public health relevance
Narrative This supplement grant will extend the original parent grant’s use of deep machine learning methods that were proposed for analyzing the raw digital images from MRI scans and apply them to raw digital voice recordings. This is an advancement over the original methods of extracting measures from the digital voice recordings and instead just analyze them in the raw form.